Enhancing memory T cell defense in the female reproductive tract.

Abstract
The sexually transmitted pathogen Chlamydia trachomatis (C. trachomatis) is the most common sexually
transmitted infection (STI) and the costliest bacterial STI. Furthermore, STI incidence and prevalence studies
estimate that women bare the highest burden of C. trachomatis infections in the United States. These infections
often progress undetected and can ascend from the vaginal mucosa into the upper reproductive tract leading to
severe health complications, including infertility, chronic pelvic pain, and ectopic pregnancies. Moreover, these
infections can increase the risk of acquiring more severe secondary infections, including Neisseria gonorrhoeae
(N. gonorrhoeae), antimicrobial-resistant strains (AMR), and Human Immunodeficiency Virus type 1 (HIV-1).
Memory T cells that become localized in the female reproductive tract (FRT) mucosa through recent infection or
vaccination in animal models have been shown to provide optimal immune protection from C. trachomatis,
leading to more rapid pathogen clearance and reducing disease severity. Therefore, generating memory T cells
against bacterial STIs in the FRT is a promising approach to enhancing cellular immunity. Previous scientific
investigations into understanding memory T cell longevity outside the circulation demonstrate that environmental
signals provided by the tissues provide critical support required for their homeostasis and survival in the lung,
skin, and gut. Yet, despite the fact that chlamydial reinfections in women are common and there is no available
vaccine, we have a very limited perspective on how the tissue environment of the FRT impacts T cell-mediated
immunity generated against STIs. Therefore, a major challenge for developing strategies, including vaccine
designs that can prevent bacterial STIs, including chlamydial infections in women, is to determine how we can
support long-lived and durable immunity in the FRT under menstrual cycle regulation. Our proposal aims to
understand the mechanism(s) driving the survival and recall of resident memory T cells (TRM) localized in the
FRT following a previous infection.

Public health relevance
Project Narrative The generation of memory T cells that remain long-lived in the female reproductive tract (FRT) can enhance host protective immunity from sexual transmission of Chlamydia Trachomatis (C. trachomatis), a causative agent of severe diseases in women and an important global human health issue. Although the local tissue environments of the FRT differentially influence tissue resident memory T cell (TRM) immune surveillance, how regionalization with different parts of the FRT impacts T cell durability to influence the memory responses against Chlamydia is unknown. The goal of this proposal is to determine the mechanisms that imprint memory T cells to preferentially reside in the uterine, cervical, and vaginal FRT mucosae in order to better inform prevention efforts and cell- mediated vaccine designs against sexually transmitted pathogens in women.